Office of the Scientific Director

The NIMH Division of Intramural Research Programs' (IRP) scientists conduct research ranging from studies into the mechanisms of normal brain function at the behavioral, systems, cellular, and molecular levels, to clinical investigations into the diagnosis, treatment and prevention of mental illness. Researchers study conditions in adults and children such as anxiety, depressive, bipolar, attention deficit hyperactivity, and autism spectrum disorders, as well as schizophrenia. Approaches include experimental therapeutics; functional and molecular imaging; genetics; behavioral, cognitive, molecular and cellular neuroscience; and epidemiology. In part, because of its state-of-the-art facilities, unique funding mechanisms, and location in the nation's capital, the IRP is viewed as a national resource, providing unique opportunities in mental health research and research training.

Susan G. Amara, Ph.D., serves as the Scientific Director for the NIMH IRP and provides oversight to a diverse mental health research portfolio that includes clinical projects on autism, women's health, depression, bipolar disorder, schizophrenia, attention deficit hyperactivity disorder, mood and anxiety disorders; and basic projects geared toward answering fundamental questions related to mental health in the areas of cognition, genetics, learning and memory, and behavior. The portfolio also includes projects aimed at exploring cutting edge technologies and approaches to neuroscience such as functional Magnetic Resonance Imaging (fMRI), Magnetic Resonance Spectroscopy (MRS) and Magnetoencephalography (MEG). The Scientific Director provides supplemental resources, as appropriate, to research projects in the IRP portfolio.

In FY2022, five new senior and tenure-track investigators came on board to lead research programs in brain development, computational psychiatry/neuroscience, pediatric neuroimaging and autism, and autoimmune brain disorders. In addition, the office hired a Scientific Diversity Advisor, who has led trainings in diversity, equity, inclusion, and accessibility (DEIA) (e.g., implicit bias in review, microaggressions, etc.) for various stakeholders.